SECONDARY ANALYSIS. SEPTEMBER 15, 2023 - SEPTEMBER 14, 2026. N01DA-22-2253. TASK ORDER NO. 75N95023F00012 (TO16)

Data and Statistics Contract (DSC6) - EXPANSION
CLINICAL COORDINATING CENTER (Emmes) - EXPANSION